Pathogenesis and Therapeutic Approaches in Primary Ciliary Dyskinesia

OVERALL
ABSTRACT/PROJECT SUMMARY
Mutations in more than 50 different genes cause Primary Ciliary Dyskinesia (PCD) by disrupting the activity of
motile cilia that facilitate mucociliary transport. Knowledge of PCD has come from studies identifying disease-
causing mutations, characterizing structural cilia abnormalities, finding genotype-phenotype relationships, and
studying the cell biology of cilia. Despite these important findings, we still lack effective treatments and people
with PCD have significant pulmonary impairment. As with nearly every other disease, a better understanding
of pathogenic mechanisms can lead us to effective treatments. To overcome some of these limitations, we
developed a PCD pig with DNAI1 disrupted. PCD pigs develop the hallmark sinonasal and pulmonary features
of human PCD including neonatal respiratory distress in newborns and mucus obstruction, inflammation,
infection, and bronchiectasis in older pigs. It is already providing exciting discoveries that provide some of the
foundation for the central theme of this PPG. The overarching goal of this program is to understand better the
pathophysiology of PCD airway disease to improve treatments and preventions that will change the lives of
people who suffer from this debilitating disease. The Projects are closely interrelated. We will address 3 main
questions: What is the early pathogenesis of PCD? What happens to mitochondrial-dependent metabolism
when ciliary beating is impaired? Will DNAI1 gene addition to ciliated epithelial cells repair the outer dynein
arm, restore cilia function, and impact disease development and progression? We hope to have an
important positive impact on accelerating discovery of new disease mechanisms and therapeutic interventions
for PCD.

Public health relevance
OVERALL NARRATIVE Primary ciliary dyskinesia is an inherited disease that causes lung illness. To develop new treatments, we must understand better how the genetic defect causes problems with the lungs. We will study a newly generated pig model of primary ciliary dyskinesia that develops disease like that in people.